Regulation and function of mitochondrial motility in neurons in vivo

Project Summary
Mitochondria are dynamic organelles which support the metabolic needs of neurons across their entire
lifetime. Previous research has sought to define the regulation of mitochondrial transport as dependent on the
activity of the neuron, including changes in energy demand. However, previous studies and unpublished data
from the Barnhart lab show mitochondrial motility is not dependent on neuronal activity. Given defects in
mitochondrial transport have been implicated with neurodegeneration, the goal of this research is to elucidate
the fundamental role of mitochondrial transport in maintaining healthy and functional neurons. I propose to
define both in vivo mitochondrial localization across the neuron and contributions of mitochondrial motility in
the function of the mitochondria in neurons. To define mitochondrial transport and function in vivo, I will use
the Drosophila melanogaster visual system with live cell imaging using genetically encoded reporters of
mitochondrial health and neuronal function. In Aim 1, I will use confocal microscopy, immunostaining and
EM reconstructions to define the relationship between mitochondrial motility, mitochondrial distribution
patterns and neuronal architecture. This aim will evaluate the relationship between neuronal structure and
overall mitochondrial localization. In Aim 2, I will use mitochondrial perturbations to assess how
mitochondrial motility affects mitochondrial health and neuronal function in vivo. These studies will define the
regulation and functional relevance of mitochondrial motility in neurons, which paves the way towards future
studies on the role of mitochondrial transport defects in disease, including in neurodegeneration.

Public health relevance
Project Narrative Mitochondria produce the essential energy needed for neurons to function properly. These organelles are dynamic and move throughout the cell during the lifetime of the neuron; however, little is known about the functional relevance of this movement of mitochondria and how it contributes to the function of the neuron. This proposal will elucidate the fundamental in vivo steady state localization of mitochondria in order to better understand how neurons maintain healthy distributions of mitochondria across their complex structures over their entire lifetime.